Mechanisms of mitochondrial genome integrity in familial and idiopathic Parkinson's disease

Abstract
Parkinson’s disease (PD) is the most common neurodegenerative movement disorder and over ten million
people worldwide are living with PD. To date, treatments are only symptomatic; they do not alter the inexorable
progression of the disease. The most common cause of familial and idiopathic PD are mutations in leucine-rich
repeat kinase 2 (LRRK2). LRRK2-associated and idiopathic PD demonstrate mitochondrial impairment, however
our understanding of the molecular underpinnings of mitochondrial dysfunction in PD is limited. In our efforts to
understand the underlying mechanisms driving mitochondrial dysfunction, we found that mitochondrial DNA
damage is a shared phenotype amongst both LRRK2-associated and idiopathic PD. Unrepaired mitochondrial
DNA damage can have major adverse cellular effects, impacting genetic and protein instability, compromising
bioenergetic function, increasing reactive oxygen species, and triggering cell death. Recent preliminary studies
by the Sanders lab has found that blocking kinase activity of ATM (a kinase that functions to sense, signal and
promote repair of DNA damage) rescues PD-induced mitochondrial DNA damage. We further observed that
ATM is activated and initiates the DNA damage response pathway. Interestingly, mitochondrial DNA repair
capacity is impaired with a concomitant increase in specific mitochondrial oxidative DNA lesions. The
overarching goal of the parental grant to understand how dysfunctional LRRK2 triggers the ATM-mediated DNA
damage response pathway, which impairs mitochondrial DNA repair capacity, leading to an increase in
mitochondrial DNA damage, ultimately promoting downstream pathogenic PD cascades. Specific to this
research supplement, we have discovered PARP is playing an important role in PD. Based on this data, Ivana
Barraza will investigate PARP1 in mitochondrial function. She will learn new technical expertise and
methodology, publish impactful research and obtain the key preliminary data for competitive T grants to launch
a successful scientific career. Overall this project will directly complement the parental grant and ongoing
experiments in the lab to understand shared pathways that drive mitochondrial dysfunction, in order to provide
new insights into PD pathophysiology and consequently lead to new therapies.

Public health relevance
Project Narrative The most common cause of idiopathic and familial Parkinson’s disease, an adult onset movement neurodegenerative disorder, are mutations in leucine-rich repeat kinase 2 (LRRK2). The overarching goal of this proposal is to understand how the DNA repair enzyme PARP1 impacts mitochondrial function. It is hoped that cellular pathways involved in maintaining genome integrity will reveal potential new therapeutic strategies to treat this devastating disease.